Improving Cardiometabolic Health with Meditative Movement in Mobility Impaired Women

More than 1 in 10 mid-life (age 35-64) Americans have mobility impairing disabilities, this is especially so for
women who have higher prevalence than men. Mid-life is a critical window for women to enhance healthy
aging, by improving health and reducing cardiometabolic (CM) risk. The higher prevalence of daily stress
encountered by mid-life women with mobility impairment has been linked to emotional health and CM disease
risk factors, such as excess abdominal fat that can lead to premature mortality. This is especially so for women
with mobility impairment (WMI) who have higher prevalence of mobility impairment, excess body fat, higher
risk for cardiometabolic risk than men, and are typically not eligible for most interventions that involve
vigorous PA. Our work combines two forms of low intensity PA meditative movement, Tai Chi and Qigong
(TCQ), in a mind-body practice described in our model, Biobehavioral Model of Effects of TCQ on Body
Composition. TCQ can be completed in a seated position and has been tested in non-impaired populations,
consistently showing improvements in body composition, as well as stress related factors and associated
dynamics (neurophysiological and hormonal) associated with abdominal fat in women. Our own preliminary
study using TCQ with WMI provides evidence of reduced abdominal fat. Reduced stress in response to TCQ is
directly observed as changes in heart rate variability and cortisol, reductions in reported emotional distress,
and behavioral indicators of emotional eating and sleep quality. These all contribute to excess abdominal fat
(measured as waist circumference WC) and strongly associated with cardiometabolic risk. Our team brings
singular expertise in the proposed TCQ intervention to be implemented, measures, and engaging with WMI.
Building on our extensive experience working with our partners, we propose to recruit a nationally
representative, diverse sample (final N=196) of WMI (age 35-64) who have a waist circumference >83 cm
(benchmark of cardiometabolic risk). We will randomize women to a 12-week, online, on-demand TQG
intervention or health education video (HEV) control, with assessments at baseline (T1), immediately post-
intervention (12 weeks; T2), and at a 24-week follow-up (T3) to determine the efficacy and sustained effects of
the TCQ intervention. We hypothesize that TCQ participants will experience (T2) and sustain (T3) significant
improvements in WC, heart rate variability (increased high frequency power) and salivary diurnal cortisol
(decreased area under the curve) (primary outcomes). We also expect that TCQ participants will experience
(T2) and sustain (T3) improvements in self-reported perceived stress and emotion regulation, depressive
symptoms and anxiety, emotional eating and sleep quality (secondary). Last we will explore a model of
biobehavioral mechanisms by which TCQ may reduce abdominal fat via physiological and behavioral pathways.
If efficacious, TCQ could have high impact improving accessible strategies to reduce stress responses and
abdominal fat as well as reducing CM risk and improving healthy aging among WMI.

Public health relevance
Project Narrative About half of all people with mobility impairing disabilities are members of the working public (1 of every 10 people under the age of 65), and the majority are women. Women with mobility impairment (WMI) have high stress and higher risk for accumulating excess body fat. Few strategies to reduce stress and risk for high body fat and accompanying cardiometabolic conditions are available or tested. The proposed online, on demand Tai Chi and Qigong practice could have high impact by improving accessible strategies to improve cardiometabolic health and aging among WMI.